A brief, task-shifted treatment to improve father depression and child outcomes in Kenya: A pilot effectiveness-implementation trial

PROJECT SUMMARY
Globally, depression is the leading cause of disability world worldwide, yet over 75% of people in low and
middle-income countries (LMIC) do not receive treatment. This gap is especially large for men. Treating men is
essential to reducing the global burden of depression given its impact on families and children with men’s
mental health (MH) predicting poor parenting and child MH. Although treating parent depression has been
shown to improve parental MH, parenting, and child MH; men and fathers have been missing MH care and
clinical trials. MH care relevant to fathers that address common barriers to MH, such as masculine norms and
economic factors, are needed. The goal of the K23 is to expand the candidate’s skillset and prepare her to
conduct independent research on scalable interventions for adult MH to improve child MH in low-resource
settings. Through a combination of coursework and seminars, scientific conferences, collaborative
publications, and mentorship from leading experts, the candidate will develop competency in 1) execution of
randomized control trials using implementation science designs; 2) exploration of mechanism of change on MH
using mixed methods; 3) understanding social determinant of health (SDH) on implementation.
The candidate will apply knowledge and skills gained through training to conduct a pilot randomized
control trial (RCT) using an effectiveness-implementation design in Kenya. The candidate will leverage existing
partnerships with AMPATH and Moi Teaching and Referral Hospital (MTRH) in Kenya. She will also build on
collaborative preliminary work with AMPATH/MTRH that showed promising proof-of-concept for ‘Learn, Act,
Engage, Dedicate’ (LEAD), a 5-session task-shifted behavioral activation intervention with motivational
interviewing and masculinity discussion strategies for fathers in Kenya. Proof-of-concept findings with nine
fathers and families were promising with high participant satisfaction and improvements in father depression,
parenting, and child MH. This supports pursuit of a pilot RCT, proposed here, using an effectiveness-
implementation Hybrid Type I design to explore preliminary effectiveness and its implementation. Specifically,
the candidate will conduct a pilot RCT with fathers randomized to either LEAD or a waitlist control group to
(Aim1) explore change in fathers’ MH; (Aim 2) explore drivers of change in father MH, father parenting, and
child MH (or non-response); and (Aim 3) explore the feasibility and acceptability of implementing a task-shifted
MH treatment for fathers in a low-resource setting. Results will inform the development of an R01 proposal for
a Hybrid trial to assess clinical outcomes of father and child MH and the impact of implementation strategies.
Together, the training, research, and partnerships in the proposed award will support testing of a scalable MH
treatment delivered by peer-father counselors with potential for engaging men and improving father and child
MH in a low-resource setting, contributing to the NIMH’s goal of maximizing public health impact of research.

Public health relevance
PROJECT NARRATIVE Men are missing from mental health care and family-focused research; their inclusion through scalable, relevant treatment can improve the burden of mental health problems especially in low-resource settings where treatment gaps are largest. The proposed K23 supports the candidate’s transition to a research career designing and testing scalable interventions for caregiver mental health to improve child mental health in low- resource settings that consider social determinants of health focused on men and father. The resulting knowledge can inform public health policy and intervention strategies to reduce the global burden of mental disorders for men, and subsequently children and family members.